Cross-talk between sarmoptosis and ferroptosis in hemorrhagic stroke

Project Summary/Abstract
Brain bleeding in the parenchyma, also known as intracerebral hemorrhage (ICH), represents 10 to 30 percent
of strokes in distinct countries around the world. Despite its lower incidence than ischemic stroke, ICH carries
higher rates of mortality and morbidity. Worse outcomes in humans with ICH have been correlated with damage
to axons in areas of the brain like the thalamus or the striatum where bleeding from small, penetrating arteries
(often affected by longstanding hypertension) tends to occur. Red blood cells accumulate in ICH and lyse and
release toxins. These include hemoglobin (Hgb) and its breakdown product hemin . Additional understanding of
how Hgb/hemin leads axons to degenerate in ICH is a strategy to fully assess and overcome disability from this
condition. Excitingly, a molecular path for programmed axonal destruction has been defined involving the protein,
sterile alpha and Toll/Interleukin receptor-1 (TIR) motif containing 1 (SARM1). SARM1's degenerative activities
in the axon emerge from its NADase (NAD+ degrading) activity in the TIR domain. This domain's importance is
highlighted by its conservation from plants to humans. In preliminary studies, we found that germline deletion of
full length SARM1 prevents axonal damage in the striatum following ICH. Since previous studies from our lab
have shown that hemin induces ferroptosis, an iron-dependent, caspase-independent form of programmed
necrosis, following experimental ICH, we are seeking to understand the cross talk between ferroptosis and
SARM1-mediated axonal destruction (sarmoptosis). Of note, we found that cortical neurons cultured from the
SARM1 knockout mice are partially resistant to ferroptotic stimuli (hemin and erastin). Moreover, agents such as
P7C3 that augment the cell's ability to make NAD+ protect against ferroptosis; conversely, FK866, which impedes
the same NAD+ synthesizing pathway makes ferroptosis worse. From these preliminary studies we propose
three aims designed to understand the interplay between ferroptosis and sarmoptosis in ICH. In the first aim, we
will leverage mice that possess a germline, homozygous, single amino acid mutation (E642A) in the NADase
domain of SARM1. Like the SARM1-/- mice, the neurons of these mice are resistant to axotomy in vitro and in
vivo. They will be used to probe whether the NADase activity is critical for ferroptosis in vitro and ICH in vivo. In
the second aim, we will address the hypothesis that hemin-induces axonal degeneration via local ferroptotic
pathways that trigger SARM1 activation. We will use sensory neurons cultured in Campenot Chambers to isolate
cell bodies from axons and query their possibly distinct responses to lethal concentrations of hemin. We will also
probe the role of ferroptosis and sarmoptosis in the destruction of corticospinal tract axons in vivo. In the last
aim, we will seek to understand whether interventions that target ferroptosis by acting in the nucleus (cell body)
can be combined with SARM1 deletion (that acts primarily in axons) in mice to reduce damage and improve
behavioral recovery over each agent tested alone. At the culmination of these studies, new mechanistic
information will emerge regarding axonal and cell body loss following ICH with clear therapeutic implications.

Public health relevance
Project Narrative Intracerebral hemorrhage (ICH), or bleeding in the brain is a type of stroke, with higher incidence in Blacks and Asians, that often leads to disability or death. Our proposal will investigate how axons, the part of the neuron that is critical for long distance communication in the brain, are programmed to degenerate after ICH. The studies will evaluate a completely new target for ICH therapeutics and how to optimize healthy outcomes after ICH.